TRANSPIRE: A Prospective Cohort Study of Lung Injury After Hematopoietic Stem Cell Transplant in Children.

Project Summary
Hematopoietic stem cell transplant (HSCT) is increasingly used for non-malignant hematologic
disorders such as sickle cell anemia and marrow failure, and complications of HSCT are more
prevalent and important as causes of long term morbidity. Improved diagnosis and treatment
and treatment are urgent issues. Lung injury is frequent after HSCT, with as many as 15% of
children transplanted having reduced FEV1, later leading to overt bronchiolitis obliterans (BO)
which is associated with high morbidity and mortality. Diagnosis of BO in adults depends on
spirometry, and evidence suggests that early diagnosis may improve chances of recovery of
lung function and survival. Small children, and even older children and teenagers who feel
unwell and are uncooperative, are unable to perform spirometry, meaning that lung impairment
is “invisible” until severe and clinically manifest. Progress in improving lung outcomes of HSCT
in children has been hindered by lack of diagnostic strategies, and by the need for a large group
of cases to allow testing of biological, pathological and diagnostic hypotheses to advance the
field. We propose assembling a prospective cohort study of all children receiving HSCT at 6
major US transplant centers. We will perform standardized prospective testing of lung function
and clinical data collection in all children in the cohort, to determine the frequency, clinical
phenotypes and risk factors for BO (Specific Aim 1). BO is a rare disease so progress will not
be made absent a multi-center cohort study that uniformly defines clinical phenotype and
prospectively collects samples, allowing retrospective study of early molecular events that
predict later disease. In Specific Aim 2 we will collect calendar and event-driven biological
samples, including serum, plasma, peripheral blood mononuclear cells and bronchiolar lavage
fluid, which will be stored and used to identify biomarkers of onset of BO and of response to
therapy. Moreover, we will collect pathological samples that will be analyzed using a pre-
existing rare lung disease pathology platform to identify genetic and anatomic changes that
define BO. Lastly, in Specific Aim 3 we will test and disseminate novel lung testing strategies,
including innovative imaging, to address the critical clinical challenge of late diagnosis of lung
impairment in children. We provide examples of essential biological studies that can only be
performed using the resources of the cohort, for which we will seek additional R01 funding.
Taken together, this cohort study can fundamentally change the paradigm of lung injury after
transplant and provide a platform for testing preventive and therapeutic treatments.

Public health relevance
Project Narrative The survival rates of stem cell transplants are improving allowing more children to be treated; as a result, more children are getting a form of lung injury called bronchiolitis obliterans as a side- effect of the transplant. In this study we will collect clinical and biological data to help figure out why children get this complication and how best to treat it. Children can’t perform some of the most helpful lung function tests used in adults because the tests require cooperation, so we will also test new methods to test lung function to identify lung injury more quickly in small children.